Vascular Smooth Muscle Protein Quality Control and Aortic Aneurysm Formation

PROJECT SUMMARY
Abdominal aortic aneurysm (AAA) is a devastating disease carrying high morbidity and mortality due to the high
likelihood of fatal dissection and rupture. There are currently no proven pharmaceutical treatments to prevent
AAA progression. VSMC degeneration contributes largely to AAA pathogenesis, but the mechanism remains
elusive. The ubiquitin proteasome system (UPS) serves as an essential protein quality control mechanism by
degrading misfolded proteins and surplus normal proteins. While proteotoxicity resulting from insufficient UPS
function has been widely accepted as an important mechanism for multiple degenerative human conditions, the
implication of UPS dysfunction in AAA is completely unknown. Our pathway analysis in human AAA tissues
revealed an association of UPS function with AAA. In a mouse model of AAA, accumulation of ubiquitinated
proteins, a hallmark of impaired UPS performance, precedes VSMC degeneration and AAA formation and is
exacerbated with disease progression. This suggests that inadequate UPS performance may act as a novel
mechanism underlying AAA etiology. MYOCD is a master switch of VSMC contractile gene program. How
MYOCD is regulated and functions in AAA is unknown. Bulk RNA-seq in VSMCs showed an enrichment of UPS-
related pathways in the top MYOCD-upregulated gene programs besides those relevant to VSMC contraction.
Forced expression of MYOCD improved UPS performance while suppressing VSMC degeneration in cultured
VSMCs and VSMC-specific MYOCD transgenic (Tg) mice at the early stage of AAA formation. MYOCD
increased the expression of NFE2L1 and KLHL3, two key players of UPS function. These lines of evidence
suggest a novel role of MYOCD in UPS function. Phosphodiesterases (PDEs), by catalyzing the hydrolysis of
cAMP and cGMP to specifically modulate cyclic nucleotide signaling, play critical roles in VSMC pathophysiology
and are proven drug targets for multiple human diseases. We found that PDE10A was the most induced PDE
family member during AAA formation, while MYOCD protein expression was suppressed. Inhibition of PDE10A
increased MYOCD protein, improved UPS performance, and suppressed AAA formation. These exciting
preliminary findings support a novel hypothesis that downregulation of MYOCD protein by PDE10A impairs UPS
performance, leading to VSMC degeneration and AAA. We propose three Aims to test this hypothesis. Aim 1
will use novel VSMC-specific Myocd knockout and Tg mice to determine the function of MYOCD in AngII-induced
AAA model. Aim 2 will use a novel UPS reporter mouse line and biochemical assays to determine the importance
of UPS function in MYOCD-regulated AAA and how MYOCD modulates UPS function. Aim 3 will determine how
PDE10 promotes MYOCD protein degradation and PDE10A functions in UPS performance and AAA formation.
This proposal will address for the first time the importance of UPS performance in VSMC degeneration and AAA
formation, and elucidate a novel regulatory cascade comprising a druggable upstream modulator (PDE10A) and
a downstream effector (MYOCD) in safeguarding UPS performance and proteostasis.

Public health relevance
PROJECT NARRATIVE Abdominal aortic aneurysm (AAA) is a devastating disease carrying high morbidity and mortality due to fatal dissection and rupture, yet there have been no proven pharmaceutical treatments for AAA prevention and treatment. The proposed studies will address a new mechanism underlying AAA pathogenesis, involving the insufficient ubiquitin proteasome system (UPS) performance-mediated proteotoxicity governed by a novel signal cascade comprising a druggable upstream modulator (PDE10A) and a downstream effector (MYOCD) of gene transcription. Successful completion of the aims will inform therapeutic targeting strategies to combat AAA.